Mindfulness Based Stress Reduction App for African American Caregivers

Abstract
There are approximately 43.5 million informal (unpaid) caregivers in the U.S., of which 5.6 million are
African American.1 Almost one third of people living with HIV/AIDS (PLWHA) report receiving care from
informal caregivers, typically friends and family.2 Informal caregivers often provide a variety of support to
PLWHA, including emotional and instrumental, financial assistance, and health advice.3-5 African American
caregivers of PLWHA have unique needs because they are more likely to experience stressors related to
intersecting sources of stigma and discrimination related to HIV/AIDS and race18,19 and a lack of access to
culturally sensitive health care providers and services,20-22 placing them at higher risk for burnout and adverse
health outcomes for themselves and their care recipients.23 Thus, while informal caregivers play a critical role
in supporting PLWHA, such caregiving can take a tremendous toll. Preventing or reducing caregiver stress is
especially important in order to sustain informal caregiving and its myriad benefits for patients’ quality of life
and health outcomes.
Mindfulness-Based Stress Reduction (MBSR) is one type of intervention that has shown promise in helping
caregivers manage stress while subsequently enhancing their mental health and well-being.9 MBSR consists
of psychoeducation focused on stress reduction and the development of an accepting and non-judgmental
attitude toward daily stressors of living.11 MBSR interventions can include activities such as guided meditations
and yoga exercises designed to help individuals build awareness of the present moment, and decrease
reactivity to stress.10-12,40
Building upon prior research regarding MBSR interventions, during Phase I, we successfully developed a
prototype mobile application (app) for caregivers entitled Mindfulness Based Stress Reduction for African
American Caregivers (MBSR-AAC). Based on the Health Stigma and Discrimination Framework,24 components
of the app focus on decreasing stress associated with intersecting sources of stigma, discrimination, and
caregiving burdens specifically associated with caregiving for PLWHA. In the present Phase II SBIR study, we
will build on Phase I findings to incorporate research-driven enhancements to the app, conduct a feasibility trial
of the enhanced app, and conduct a randomized clinical trial to examine the effectiveness of the app in
reducing caregiver stress. If proven to be effective, the MBSR-AAC app could have a positive impact on the
well-being of African American caregivers that serve as a critical pillar of support for many PLWHA.

Public health relevance
Project Narrative African American caregivers of PLWHA have unique needs because they are more likely to experience stressors related to intersecting sources of stigma, discrimination, and caregiving burdens specifically associated with caregiving for PLWHA. The proposed project will enhance and finalize Phase I app development and evaluate its effectiveness in a randomized controlled trial. The project has high public health significance because of its potential to provide an accessible, easy to use mindfulness-based support tool for African American caregivers that could reduce stress, mitigate the harm of intersecting stigmas, and strengthen the caregiver-care recipient relationship.